Bile acid-mediated OEA-PPARa signaling in food intake regulation

PROJECT SUMMARY/ABSTRACT
More than half of adults are considered obese or overweight in the U.S. One important risk factor
for obesity or overweight is considered to be excessive food intake. Currently, only five drugs are
approved by FDA as an anti-obesity drug. However, some adverse effects have been reported.
Thus, a novel approach or complementary method is necessary for obesity and metabolic
diseases. For this, modulation of bile acids (BAs) is expected to be a potential approach because
BAs are involved in glucose homeostasis and energy expenditure. Previously, we reported that
BAs act not only as signaling molecules involved in energy expenditure and glucose homeostasis
but also as regulators of food intake in the intestine. The structure of BAs, particularly the position
of the hydroxyl groups of BAs impacts food intake through intestinal effects: (1) modulating the
activity of N-acyl phosphatidylethanolamine phospholipase D (NAPE-PLD), which produces the
anorexigenic bioactive lipid oleoylethanolamide (OEA), or (2) regulating lipid absorption and the
gastric emptying-satiation pathway. Our preliminary data show that 16α-hydroxylated BAs,
pythocholic acid increased OEA and decreased food intake in mice. However, the role of
pythocholic acid in mammals is not completely known because 16α-hydroxylated BAs are not
naturally found in mammals. We will examine 1) a detailed hypophagic mechanism of pythocholic
acid, 2) the interaction between 16α-hydroxylated BAs and NAPE-PLD, and 3) the effect of 16α-
hydroxylated BAs producing enzymes for modification of BA composition in mice.

Public health relevance
Project Narrative Food intake control is considered a crucial strategy for the prevention of obesity and metabolic diseases because a 5% reduction of body weight significantly improves abnormality of metabolism in the obese patient. Bile acids which are synthesized in the liver and secreted into the intestine regulate food intake in the intestine by regulating lipid metabolism. This project is to determine the potential effect of unique bile acids, pythocholic acid in food intake regulation for obesity and metabolic disease treatment.